Mechanisms of commensal bacteria induced humoral immunity

The microbiome affects many aspects of human health and has been linked to diseases such as
obesity, inflammatory bowel disease, diabetes, and allergy, The balance between host and commensal
bacteria is well maintained in most healthy individuals. One host factor that contributes to intestinal
homeostasis is antibody of the lgA subclass. Plasma cells that produce lgA are found in mucosa! tissues such
as the lamina propria of the gut, but they can also be found in systemic sites including the bone marrow.
However, high levels of bone marrow lgA are only found in the presence of certain consortia of bacteria.
Increased frequencies of bone marrow lgA-secreting plasma cells are associated with increased concentration
of serum lgA that has been shown to be protective in a sepsis model of polymicrobial dissemination. The
mechanisms by which bacteria induce systemic lgA responses are unknown. The main goal of this proposal is
to take an unbiased approach to defining gene-level mechanisms used by commensal bacteria to induce
systemic lgA Additionally, we will examine how inter-species interactions contribute to systemic lgA specificity.
Together, this proposal will provide a framework for understanding how systemic antibody responses are
induced in response to commensal bacteria. This understanding could lead to novel therapies aimed at
maintaining intestinal homeostasis or using commensal bacteria as a vaccine delivery system. This proposal
will support the overall vision of our research program to understand the complex interplay at the interface of
bacteria and host by deciphering gene-level mechanisms used by bacteria to induce lgA responses.

Public health relevance
The microbiome is composed of complex communities of bacteria that dynamically interact the each other and with their host Secretion of lgA antibodies helps maintain intestinal homeostasis and promotes healthy microbial communities that are associated with positive health outcomes in humans. The goal of this proposal is to define the bacterial properties and gene-level mechanisms that promote lgA production throughout the body.